The Caregiver Resource Room: Enhancing Support for Caregivers of Alzheimer's Disease and Related Dementias (ADRD)

PROJECT SUMMARY/ABSTRACT
With an estimated 6.5 million cases of Alzheimer’s disease and related dementias (ADRD) diagnosed in the
United States in 2022, the health and well-being of ADRD caregivers is of critical importance. Promoting the
health and well-being of ADRD caregivers is an effective way to support these unpaid staples of ADRD care.
Although interventions targeting ADRD caregivers continues to accelerate, little attention has been paid to
caregivers’ use of supportive services, which remains strikingly low. The objective of this K99/R00 application
is to enable Dr. Falzarano to develop the necessary expertise to design, implement, and evaluate studies
focused on leveraging technology to support and address ADRD caregivers’ multifarious needs. In the K99
phase, Dr. Falzarano will work toward achieving five training objectives that will prepare her to transition to
become an independent investigator who designs and evaluates evidence-based technologies to enhance
tailored caregiver support. First, she will extend her knowledge in substantive areas including dementia
caregiving and front-end and back-end software development. Second, she will learn how to develop,
implement, and test behavioral interventions with an emphasis on collaboration with community partners.
Third, she will receive training in statistical methods to examine feasibility, acceptability, and preliminary
effectiveness in randomized controlled trials (RCTs). Fourth, she will learn about measurement development
and psychometric validation of assessments for ADRD caregivers. Fifth, Dr. Falzarano will pursue professional
development activities, particularly in the areas of grant writing, leadership, and integration of research and
web development teams. The four proposed research aims were chosen to complement the areas identified for
career development. Aim 1a will provide the requisite training and experiences to provide Dr. Falzarano with
the critical skills needed to conduct the proposed study. Aim 1b will include interviews with ADRD caregivers to
identify needs, awareness of, barriers to, and willingness to use services. Aim 1c will leverage key stakeholder
(dementia-care experts) input to identify existing services corresponding to areas of need identified in Aim 1b.
Aim 2 will leverage data collected from caregivers and stakeholders to inform the iterative development and
design of the Caregiver Resource Room (CRR) website, which will include a digital self-assessment tool using
machine learning models to identify and categorize needs and provide an output of targeted service
recommendations. Aim 3 will include an analysis of the tool’s content, design, features, and services output,
which will be iteratively refined based on ADRD caregiver feedback. A randomized controlled trial will be
conducted in Aim 4 to determine the feasibility, acceptability, and preliminary efficacy of the CRR as a tool to
enhance awareness of and access to relevant services to address unmet needs and improve mental health.
The proposed research is well-aligned with the NIA’s strategic initiative to foster the development of research
scientists in aging and to develop and test promising interventions to improve ADRD caregiver outcomes.

Public health relevance
PROJECT NARRATIVE The multifarious needs of ADRD caregivers often remain unaddressed, and the utilization rate of supportive services remains strikingly low, with many caregivers uncertain about what services may be right for them, what exists, and how to access them. There is a need for a robust, reliable tool that comprehensively evaluates ADRD caregiver needs with a mechanism to connect needs with existing services, thereby overcoming barriers that ADRD caregivers face in accessing needed supportive care. The proposed project seeks to iteratively develop and test an online self-assessment and tailored referral platform, grounded in machine learning principles and informed by stakeholder perspectives, to address needs and enhance knowledge and use of relevant services, with the overall goal of linking ADRD caregivers with relevant support and thereby promoting their mental health and well-being.